Comparative study of gene regulatory and structural mechanisms in Lamin-related cardiomyopathy

PROJECT SUMMARY
LMNA-related dilated cardiomyopathy (LMNA-DCM) is one of the most severe forms of adult-onset DCM and
results from heterozygous loss-of-function mutations in Lamin A/C (LMNA), a key nuclear lamina component.
Currently, no therapeutic interventions exist for LMNA-DCM, primarily due to an incomplete understanding of its
molecular pathogenesis. This proposed study aims to directly compare two long-standing prevailing hypotheses
regarding LMNA-DCM pathogenesis, the gene regulatory hypothesis and the structural hypothesis. The
gene regulatory hypothesis proposes that Lamin A/C reduction causes relaxation of lamina-associated
heterochromatin domains (LADs) causing pathogenic gene de-repression, while the structural hypothesis posits
that Lamin A/C reduction weakens the nuclear envelope causing pathogenic nuclear envelope (NE) rupture. No
studies have compared these mechanisms directly or examined their potential interrelation, a gap we aim to fill
to advance mechanistic understanding of this disease. In preliminary studies, we unveiled that Lamin A/C’s
requirement in cardiomyocytes arises during the postnatal fetal-to-adult heart maturation. This maturation period
involves the repression of fetal gene programs and strengthening of the nuclear envelope to withstand expanding
sarcomeres, both processes potentially relying on Lamin A/C’s gene regulatory and structural roles. Thus, our
central hypothesis is that Lamin A/C is essential for maintaining LAD-associated gene repression and/or
preventing NE rupture during postnatal cardiomyocyte maturation. To test this hypothesis, we will use two
innovative mouse models: one with a cardiomyocyte-specific Lmna knockout (LmnaCKO) and another with a
pathogenic LMNA-DCM frameshift mutation (LmnaFS), both of which expose Lamin A/C’s requirement during this
maturation stage. Aim 1 will determine whether LmnaCKO and LmnaFS mice develop LAD disruption and
associated de-repression of LAD-associated genes during postnatal cardiomyocyte maturation. Aim 2 will
determine whether cardiomyocytes of LmnaCKO and LmnaFS mice exhibit NE rupture, independently or
concurrently with LAD disruption, during this maturation phase. Aim 3 will assess the contributions of the LAD
disruption and NE ruptures to the development of DCM. We will use LINC complex disruption to rescue LMNA-
DCM in our mouse models, and examine whether LAD disruption or NE ruptures are primarily responsible for
the disease. The anticipated impact of this study is to provide decisive evidence supporting one of these
prevailing hypotheses, thereby accelerating the development of therapeutic strategies for LMNA-DCM.

Public health relevance
PROJECT NARRATIVE Our study aims to determine the dominant disease mechanism responsible for cardiomyopathy caused by mutations in Lamin A/C. By investigating the two prevailing models of disease mechanisms, we will determine whether defects in Lamin A/C's role in gene regulation or defects in Lamin A/C's role in physically strengthening the nuclear envelope are the primary contributors. This information will help accelerate the development of effective therapeutic strategies for Lamin A/C-associated cardiomyopathy.